CYTOGENIC AND MOLECULAR ANALYSIS OF CHROMOSOME 9P GENDER DETERMINATION

This study will screen the DNA and chromosomes of individuals with XY sex reversal for microdeletions of genetic loci located on the short arm of chromosome 9.